In Vivo Function and Metabolism Evaluation of Glaucomatous RGCs by Two-Photon Scanning Laser Ophthalmology

PROJECT SUMMARY
Glaucoma, the most common worldwide cause of irreversible blindness, is characterized by progressive
dysfunction and death of retinal ganglion cells (RGCs). We recently employed confocal scanning laser
ophthalmoscopy (cSLO) to successfully obtain in vivo Ca2+ imaging with mouse RGCs expressing jGCaMP7s, a
genetically encoded calcium indicator. Thousands of ON, OFF, and ON-OFF RGCs with characteristic responses
to light stimulation are readily detected in living animals through this non-invasive in vivo imaging platform. Here
we seek to develop a more advanced, first-of-its-kind two-photon (2P)-SLO platform with patterned stimulation
and multiple detection channels. Through a multidisciplinary collaboration with expertise in in vivo optical
imaging, RGC pathophysiology, and retinal neural circuitry and visual processing, we will use complementary
imaging techniques and state-of-the-art analysis protocols to understand naïve RGC physiology in real time. We
recently extended our original mouse silicone oil-induced pupillary blocking and ocular hypertension (SOHU)
model to recapitulate phenotypes of two forms of glaucoma: a chronic model with moderate IOP elevation and
mild RGC neurodegeneration; and an acute model with greatly elevated IOP and severe neurodegeneration.
Importantly, SO removal reduces IOP to normal almost immediately, allowing better exploration of the effects of
IOP lowering treatment and combined treatment with neuroprotection strategies. Thus, we will determine the
longitudinal functional and metabolic changes of glaucomatous RGCs, under clinically relevant models, both
before and after IOP normalization and/or neuroprotective treatments. These data will deepen our understanding
of the pathophysiology of glaucoma, towards finding much-sought biomarkers to better predict progression, and
create more relevant endpoints for developing treatment to restore RGC physiology in vivo.

Public health relevance
PROJECT NARRATIVE A thorough understanding of longitudinal retinal ganglion cell (RGC) functional and metabolic changes is critical for timely detection and treatment of glaucoma, accurate assessment of its progression, and development and testing of targeted neuroprotective therapies. The proposed experiments will develop advanced, first-of-its-kind two-photon in vivo retinal imaging platform to determine dynamic functional and metabolic features of glaucomatous RGCs at both bulk and single-cell levels using our newly developed inducible and reversible ocular hypertension animal models. The experiments have the potential to discover previously unappreciated glaucoma signatures for detecting, monitoring, and evaluating the disease and its progression.